MARC Program at the University of Texas at Dallas

PROJECT SUMMARY
Institutional data from the University of Texas at Dallas (UTD) has uncovered that our underrepresented (UR)
undergraduate students are less likely to participate in research activities because of their lack of laboratory
training, lack of familiarity with biomedical careers upon college entry, and overall inability to volunteer their time
to research because of their need to work for pay. Despite strong research participation from our overall
undergraduate population, we are unable to garner the same representation from underrepresented minority
(URM) students, students with disabilities, or financially challenged students even though UTD is a diverse
STEM-focused, research-intensive university located in the fourth largest metropolitan area of the US. We
designed the MARC at UTD program to address our shortcomings and promote equity in biomedical research.
We anticipate a 500-1000/yr pool of STEM undergraduates who would be eligible to apply to the MARC at UTD
program. Our research strengths include imaging, computational approaches, engineering, neuroscience,
molecular biology, and entrepreneurship development aimed at scientists. The specific objectives of this three-
year (per cohort) program are to: 1) To equip a select group of carefully identified undergraduates (i.e., MARC
fellows) who do not need previous research experience with the necessary skills to thrive in a biomedical
research laboratory; 2) To financially support this cohort of select MARC fellows who would otherwise need to
work to allow them the necessary time to engage in continuous, productive biomedical research; and 3) To
provide career mentorship and professional skill development to these MARC fellows. In order to equip MARC
fellows with laboratory skills, they will initially enroll in an Introduction to Biomedical Research Skills Course. This
course will train students in techniques commonly utilized in biomedical research, in safe and ethical laboratory
practices and statistics, and in scientific communication prior to starting research. Following this, our MARC
fellows will complete biomedical research with a final objective of presenting at a national research conference,
preparation of a manuscript for publication, and successful application to a biomedical graduate program. This
extensive 2.5 years of research will include academic year research, one summer at UTD, and one summer with
an external partner. The MARC program expects to support 30 students over five years (three separate cohorts).
MARC participants will be matched with a faculty research mentor, a career mentor, and a near-peer mentor to
guide them through the various facets of scientific discovery and professional development. Of particular
importance is the creation of an individual development plan (IDP) that will fit the needs and experiences of each
participant. Upon program completion, MARC fellows will be prepared to excel in graduate research in
biomedicine.

Public health relevance
PROJECT NARRATIVE The University of Texas at Dallas (UTD) has significant potential to capitalize on its status as one of “most diverse” campuses in the US along with its robust STEM programming to successfully launch and sustain the MARC at UTD program. By developing the MARC at UTD program, underrepresented minority students, low income and first-generation students, and students with disabilities can be offered carefully tailored opportunities to participate in biomedical research and be prepared to compete and succeed in graduate studies.